CANCER CENTER ADMINISTRATION

7.6 Cancer Center Administration The mission of the Chao Family Comprehensive Cancer Center (CFCCC) Administration is to provide support, utilize resources effectively, and to achieve the highest standards of administrative excellence for the Cancer Center's research enterprise. This is accomplished through an effective infrastructure that provides efficient, timely, and streamlined assistance to Cancer Center leadership and Members. Administration provides a full range of analysis, operational, management, and information services